Activity-dependent astrocyte glucose dynamics regulate hippocampal neurogenesis

Abstract
Newly generated neurons in adult hippocampal neurogenesis face a critical survival phase immediately after
birth, heavily reliant on glucose-derived energy. However, the competitive and activity-dependent acquisition
and utilization of this fuel remains poorly understood. This study utilizes advanced tools to decipher how
hippocampal neural activity governs astrocyte glucose metabolism and lactate production, ultimately dictating
the fate of young newborn neurons. Three specific aims guide our investigation. Aim 1 pinpoints specific
hippocampal interneurons that regulate astrocyte glucose uptake and metabolism, forging a crucial link
between neuronal circuit activity and activity-dependent astrocyte glucose dynamics. Aim 2 unravels the
mechanisms behind lactate's role in newborn neuron survival, determining whether it directly fuels them or
activates critical signaling pathways. Aim 3, inspired by observations of impaired neurogenesis and glucose
metabolism in Alzheimer's disease, investigates whether astrocytes hold the key to this decline. Their lactate
dynamics and associated key metabolic enzymes for lactate and glucose will be analyzed for defects. Glucose
uptake will be genetically manipulated to definitively establish its role. By uncovering the interplay between
neuronal activity, astrocyte metabolism, and lactate, this project aims to examine the underlying mechanisms
of activity-induced adult neurogenesis in health and disease. It paves the way for novel neuroimaging
techniques and offers new insights for therapeutic development in neurodegenerative disorders.

Public health relevance
Adult brains continuously generate new neurons, but these young cells face a critical survival phase requiring significant glucose-derived energy. This study uses novel techniques to visualize key metabolites in freely moving mice, allowing us to observe interactions between neurons, astrocytes, and newborn neurons. By analyzing both healthy and Alzheimer's-affected brains, we aim to understand how young neurons secure energy and potentially develop interventions to promote their survival, potentially even slowing aging or treating neurodegenerative diseases.